Multi Union National Disaster Preparedness and Response Training program

HDPT Project Summary The ICWUC seeks to continue its range of disaster response programs to
prepare workers and communities to protect themselves (246 disaster response programs to 3,657
workers and volunteers for 24,142 contact hours, many being short awareness classes).
We will launch a major trainer initiative to conduct disaster training and Train the Trainer (TtT) classes in
Spanish or bilingually. This builds off the Spanish Disaster TtT classes we held in Houston after Hurricane
Harvey and then four in Puerto Rico after Hurricane Maria. We will train new bilingual trainers and further
the skills of the 28 trainers and partner staff who delivered these programs using participatory adult
education techniques. The new worker trainers will conduct Disaster awareness training either as
preparedness or post disaster to remediation workers. The ICWUC Center, AFSCME, LCLAA and NCOSH
will each conduct at least one Spanish Disaster TtT class with language determined in each location.
We will include two new partners, the American Federation of State, County and Municipal Employees
(AFSCME), the largest public sector union with members who perform a wide range of jobs after a disaster
and the Association of Occupational and Environmental Clinics (AOEC), a national network of experienced
occupational health professional with a range of expertise in chemical and biological exposures and their
health effects in the context of a disaster.
We will continue our Plume Software and infectious disease pandemic classes, authorize trainers in the
OSHA 5600 Disaster Site Worker and continue our work with a number of other NIEHS Grantees. Field
programs will include Disaster and Trauma awareness through our partners, disaster First Aid/CPR/AED
(using ASHI curriculum and NIEHS Protect Yourself booklets) and Mold, Muck and Gut.
We will continue to collect pre/post training data of participants in our Plume class to evaluate workplace
changes by participants and to evaluate how worker trainers who assist this class utilize this knowledge
and skills in the workplaces and communities. We will evaluate participant views on the benefits of disaster
awareness training.

Public health relevance
HDP Project Narrative The ICWUC seeks to continue its disaster response programs (in Spanish and English) to prepare workers and communities to protect themselves primarily by preparing worker trainers to deliver disaster awareness classes. We will include two new partners, the American Federation of State, County and Municipal Employees (AFSCME), and the Association of Occupational and Environmental Clinics (AOEC), continue Plume Software and pandemic and our work with other NIEHS Grantees.